Predicting slips during ladder climbing: novel methods for assessing shoe-rung friction

Project Summary
Falls from ladders cause severe injuries and fatalities among workers. Despite well-established epidemiology
that identifies slips and falls from ladders as an important problem, little is known regarding how ladder design
or an individual's body affects slip and fall risk. Furthermore, no tests exist to assess the friction performance of
ladder rungs. This knowledge gap is a major barrier in designing safer ladders and verifying their efficacy. The
objective of this NIOSH R01 research study is to develop new methods for assessing friction performance of
ladder rungs, friction requirements of ladder climbing, and their relationship with the occurrence of slipping
during ladder climbing. The long-term goal of our research is to develop a set of ladder safety guidelines
(ladder design guidelines and safe climbing guidelines) that can lead to a substantive reduction in the number
of severe injuries and fatalities caused by ladder slip-and-fall events. This research is a continuation of an
existing line of research (originally funded by a NIOSH R21 grant) where we have developed novel methods of
measuring human subject responses to perturbations during ladder climbing. The preliminary research by the
team has led to five published peer-review papers (and a sixth in review) as well as 15 conference
abstracts/proceedings. The study consists of four aims. Aim 1: Quantify the impact of ladder design on
required coefficient of friction (RCOF). Based on preliminary data, we hypothesize that friction requirements
will be influenced by the angle of the ladder (H1.1) and the rung design (shape: H1.2; size: H1.3). Aim 2:
Quantify the impact of the individual factors, height, obesity, and sex, on RCOF. We hypothesize that height
(H2.1) will be negatively correlated with friction requirements. Furthermore, we hypothesize that differences will
exist across obesity groups (H2.2) and sexes (H2.3). Aim 3: Quantify the impact of ladder design on traction
performance, measured by the available coefficient of friction (ACOF). We hypothesize that rungs designated
as “non-slip” will perform better than those without this designation (H3.1); and that size (H3.2), orientation
(H3.3) and shape (H3.4) will influence friction performance. Aim 4: Identify the ACOF measurement methods
that best predict slipping. We hypothesize that slipping can be predicted with available friction and friction
requirements (H4.1) and that different testing methods will vary in their ability to predict slipping (H4.2). This
research project is expected to lead to specific ladder design interventions for safer ladders such as
recommendations for ladder angle, rung size, and rung shape. Furthermore, this project is expected to lead to
new validated testing methods that can be utilized in industry to discriminate between high and low traction
rung designs to enable future innovations in ladder safety design. This research addresses several of NIOSH's
Program Grid Intermediate Goals that mention falls from different levels or falls from ladders: 6.2(A)
(Construction), 6.13 (B) (Services), 6.16 (B) (Wholesale/Retail), 6.18 (A) (Mining).

Public health relevance
Project Narrative Slip and fall accidents involving ladders are a significant source of severe injuries and fatalities in the working population. An urgent need exists to quantify the contribution of ladder design and individual factors on slip and fall risk. This project will develop new knowledge on risk factors for slip and fall accidents and will develop new methods for assessing rung friction. It is expected that this foundational knowledge will lead to design interventions that can reduce injuries and save lives from occupational ladder-related falls.